Simplified Accessible Vehicle and Robotic wheelchair

The goal of this research is to examine the feasibility of designing a powered wheelchair to
make it more capable of being transported in a minimally modified vehicle and/or electric
powered vehicle of which will reduce the cost for modifications and maintenance making
mobility and transportation more accessible and available to a larger population of veterans
more reliably. This will be accomplished by determining design criteria of the power wheelchair
based on key dimensions of common vehicles. Then, a power wheelchair concept will be
iteratively designed with the use of input from end-users and caregivers by individual interviews
and focus groups. Lastly, based on the determined design dimensions and feedback gathered
from end-users and caregivers, a 3D computer-aided design model will be created for future
manufacturing of a prototype.

Public health relevance
Roughly 6 million people with a disability experience transportation difficulties as a result of the lack of accessible transportation, scheduling complications, high costs and limited availability for nonmedical purposes. According to the US Department of Transportation, some of the most common strategies to compensate include reducing day-to-day travel, asking others for rides, limiting travel to daytime and giving up driving. As a result, there is a significant demand for more accessible transportation options. Unfortunately, acquiring a personal accessible vehicle is financially difficult due to the extensive cost of the modifications that are necessary for power wheelchairs to fit, specifically. Although such modifications are able to be performed today, the convertibility of future electric vehicles raise additional design challenges due to the location of the batteries and electrical components.